Genetic Regulatory Network in Craniofacial Development

Abstract
This competitive renewal continues our efforts to decipher the skeletogenic signaling network underlying
craniofacial development and disease. The craniofacial skeleton consists of the viscerocranium and
neurocranium, which are subdivided into the calvarium and chondrocranium. During calvarial development,
cranial sutures serve as the growth center for skeletogenesis. Defects in suture morphogenesis resulting in
premature closure cause craniosynostosis, a devastating childhood disease affecting 1 in ~2,000 individuals.
Although human genetic analyses have identified genes associated with the pathogenesis, little is known about
the regulation of suture closure essential for the development of a healthy skull. In the previous funding
periods, we identified and isolated skeletal stem cells residing in the suture mesenchyme. These suture stem
cells (SuSCs) are essential for calvarial development in infants, homeostatic maintenance in adults, and injury-
induced bone repair in a cell-autonomous fashion. The in vivo clonal analysis further demonstrates calvarial
bone regeneration at a single-cell level. Implantation of SuSCs to an injured site shows not only long-term
survival but also facilitation of bone healing via direct engraftments in which the implanted stem cells give rise
to osteogenic cell types in the replacement of the damaged tissue. These discoveries also have led to the
identification of BMP type I receptor BMPR1A as a stem cell regulator whose ablation in SuSCs disrupts their
stemness; the finding of stem cell exhaustion as a new mechanism of craniosynostosis; the purification of
human SuSCs-based on cell surface expression of BMPR1A. SuSC characterizations have had tremendous
impacts on our understanding of disease etiology and craniofacial reconstruction. In this proposal, we continue
our in-depth evaluations of SuSCs by examining their regulation by the crosstalk of skeletogenic signaling
essential for healthy development and homeostasis of the calvarium. We will concentrate on the elucidation of
molecular and cellular mechanisms underlying craniosynostosis caused by the dysregulation of SuSCs.

Public health relevance
Narrative This proposal investigates basic genetic elements controlling the formation of a healthy skull during craniofacial skeletogenesis. Using genetically modified mouse strains and single-cell profiling approaches, we elucidate molecular and cellular mechanisms underlying skeletal stem cell-mediated calvarial bone development and disease. The results obtained are highly relevant to the health of human development in craniofacial deformities, e.g. craniosynostosis and cleidocranial dysplasia, and have the potential to gain insights into preventive and therapeutic strategies for human diseases.